Discovery of novel antivirulence drug targets in C. difficile by systematically demystifying its genetic network controlling toxin biosynthesis

Project Summary
Clostridioides difficile infection (CDI), an antibiotic-associated diarrhea, is a leading cause of hospital-acquired
infection and death. The traditional antibiotics metronidazole (MTZ) and Vancomycin (VAN) have been the
mainstay treatment for CDI for over 30 years. However, these drugs are now associated with increased clinical
failure. Postdoctoral research by the candidate revealed mechanisms of resistance to these agents and showed
that resistance promotes poor clinical outcomes. Past research also highlighted the need for new CDI
therapeutics that are microbiome-sparing and allow the gut microbiota to rebound during CDI therapy. This
proposal tackles the need for microbiome-sparing CDI drugs, by seeking to explore genetic mechanisms that
regulate the production of virulence toxins by C. difficile. The discovered gene determinants will represent
potential drug targets and will help to fill the knowledge void concerning druggable metabolic and regulatory
processes that control toxin production in C. difficile. The overarching hypothesis of aim 1 is that since toxin
biosynthesis is a secondary metabolic step it will be subject to cellular genetic perturbations. We will identify
gene determinants and cellular pathways that negatively affect toxin biosynthesis by high-throughput screening
of transposon mutants. The key proteins will undergo druggability assessment and validated for effects on
virulence using in vitro and in vivo methods. Aim 2 will adopt chemical genomic strategies on anti-virulence
molecules to identify targets that are druggable. This study will advance fundamental scientific knowledge of C.
difficile pathogenesis toward the discovery of new therapeutic agents. The K99 phase will be mentored by an
exceptional panel of experts in C. difficile pathogenesis, drug discovery, and systems biology, to enable the
development of skills in bioinformatics and high throughput screening. This support combined with the
candidate’s expertise in molecular microbiology and protein biochemistry will facilitate the smooth transition to
an independent scientist during the R00 phase. The institutional environment and support for career
development are both strong. These studies will lay the foundation for future research aimed at developing
innovative therapies that block target toxin biosynthesis in C. difficile and understanding of its pathogenic
physiology.

Public health relevance
Project Narrative Clostridioides difficile infection (CDI) is a leading cause of hospital-acquired diarrhea due to dysbiosis caused by broad-spectrum antibiotics. Cellular pathways affecting toxin biosynthesis is promising for anti-virulence drugs that spare the beneficial gut microbiota. This proposal seeks to identify and characterize drug targets within such pathways, from which to develop anti-virulence drugs for CDI.